Enhancing Inclusive Mentorship: Valuing Diversity and Ensuring Accessibility and Belonging for Newcomers and Children of Newcomers to Become Health Equity Researchers

PROJECT SUMMARY
A critical component of impactful health equity research is involving and mentoring academic and community
researchers from diverse backgrounds, particularly those with lived experience related to the structural
inequities and health disparities we aim to eliminate. The proposed DEIA Mentorship Supplement builds on our
parent study that tests the effectiveness of three nested levels of intervention to reduce disparate adverse
impacts of the COVID-19 pandemic (psychological distress, daily stressors, and economic precarity) and
increase protective factors (social support, critical awareness of/access to resources, English proficiency,
cultural connectedness, and mental health service use) among Latinx and Black immigrants and refugees. Our
community-based participatory research (CBPR) approach emphasizes collaborative knowledge generation,
which ensures our research is rigorous, innovative, responsive, and equity-focused. Resources to expand and
create a mentorship structure that builds on the strengths of bilingual newcomers and children of newcomers
who want to become biomedical and social science health researchers will advance our research impact. We
propose an anti-oppressive, co-learning, multi-tiered mentoring model that we will assess, sustain, and
disseminate. Our outstanding team includes co-mentors involved in the parent study and a group of extremely
promising mentees at multiple levels who want to become health equity researchers. An important innovation
is our inclusion of not only graduate students but also project staff and community partner mentees who want
to enter graduate and/or medical school, but who have not had the opportunity to pursue a typical professional
trajectory because of needing to work to support themselves and their families and other issues related to
newcomer experiences. The supplement would advance our research and mentoring activities (and health
equity research more broadly) through three aims: 1) formalize and implement anti-oppressive, team-based,
co-learning mentoring processes for student, staff, and community mentees to engage in structured research
mentorship, career path mentoring, and wellness support; 2) leverage the parent study quantitative and
qualitative data to conduct mentee-led mixed methods analyses of emerging research questions not related to
intervention impacts; and 3) improve dissemination of parent study and proposed supplement research
findings through additional peer-reviewed manuscripts, innovative bilingual multimedia materials for community
partners and members, and team conference presentations to maximize impact. One of the strengths of the
mentee team who have lived experiences as newcomers or children of newcomers is that they have innovative
and culturally grounded ideas for asking research questions that are most relevant to their communities and
disseminating the results in novel, bilingual formats that are usable and accessible to their communities. In
sum, the proposed research and mentoring plan will provide critical opportunities for enhancing the impact of
the parent grant and advancing our research.

Public health relevance
PROJECT NARRATIVE The proposed supplement “Enhancing Inclusive Mentorship: Valuing Diversity and Ensuring Accessibility and Belonging for Newcomers and Children of Newcomers to Become Health Equity Researchers” provides an opportunity to increase impact and expand mentorship on our study of multilevel interventions to address the negative mental health and economic effects of the COVID-19 pandemic on Latinx and African refugees and immigrants. We will create a mentorship model that 1) builds on the strengths of bilingual newcomer and children of newcomer students, staff, and community members who want to become health researchers; 2) provides support and opportunities for them to achieve these goals through team-based mentored research experiences and holistic support; and 3) advances our research through additional analyses of study data to examine research questions of importance to newcomer communities related to promoting newcomer mental health.